Skin Cancer Risks and Risk Prediction in Patients with Actinic Keratosis

PROJECT SUMMARY
Research: Actinic keratoses (AKs) are pre-cancerous skin lesions that arise in the setting of chronic sun
exposure and affect tens of millions of people in the United States each year. AKs have a risk of transformation
to cutaneous squamous cell carcinoma. The majority of AK clinical care and research focuses on the individual
AK and its risk of malignant transformation. However, there is evidence that the presence of AKs may be
associated with increased risk of squamous cell carcinoma and other types of skin cancer (melanoma and
basal cell carcinoma) for the patient as a whole. Though they are not typically used this way, AKs may be an
important clinical biomarker of skin cancer risk, including melanoma, squamous cell carcinoma, and basal cell
carcinoma. Unfortunately, there are no specific recommendations for clinicians to follow for skin cancer
surveillance or early detection in patients with AKs. This project will address key knowledge gaps: to examine
the absolute risks of skin cancer in patients with AKs, which are unknown (Aim 1); to understand the care
currently being provided to patients with AKs, which is uncharacterized (Aim 2); and to develop a skin cancer
risk prediction model for patients with AKs, which has not previously been done (Aim 3). The overarching goal
is to provide evidence to guide clinical care and form the foundation for future recommendations on skin cancer
surveillance and early detection in patients with AKs, a large and high-risk group. Candidate: Dr. Mackenzie
Wehner, MD MPhil is an Assistant Professor of Health Services Research and of Dermatology at MD
Anderson Cancer Center. She completed her undergraduate degree at Yale University, medical school at
Stanford University, a Master's in Epidemiology at the University of Cambridge, and residency and post-
doctoral research fellowship at the University of Pennsylvania. Her career goal is to become an independent,
R01-funded physician scientist in patient-oriented skin cancer research and through her research to decrease
the burden of skin cancer in the United States. Environment: During this award period Dr. Wehner will devote
at least 75% of her time to research and 20% to clinical care of patients at high risk of skin cancer, including
those with AKs. Her primary mentor, Dr. Sharon Giordano, and co-mentor, Dr. David Margolis, are proven
mentors and experts in patient-oriented research in cancer. The exceptional training environment in cancer
research at MD Anderson will offer Dr. Wehner an outstanding opportunity to launch her career as an
independent physician-scientist. Career Development: Dr. Wehner will have support from an experienced and
diverse advisory committee and will focus her training on developing skills and experience in 1) health services
research and large administrative datasets, 2) risk prediction modeling and tools development, and 3)
incorporating genetic data in epidemiologic analyses. Completion of the proposed research and career
development plan will serve as a platform upon which Dr. Wehner can successfully transition to independence
and pursue an impactful career focused on patient-oriented skin cancer research.

Public health relevance
PROJECT NARRATIVE Actinic keratoses are common pre-cancerous skin lesions that can transform into cutaneous squamous cell carcinoma and whose presence may also be associated with increased risk for other types of skin cancer (melanoma and basal cell carcinoma). In this project, we will determine the absolute risks of skin cancer over time in patients with actinic keratosis, which are unknown; assess what skin cancer related follow-up care is currently being provided to patients with actinic keratosis, which is uncharacterized; and develop a skin cancer risk prediction model for patients with actinic keratosis, which has not previously been done. Completion of this project will directly inform recommendations for skin cancer surveillance and early detection in patients with actinic keratosis, a high-risk group comprised of tens of millions of patients each year in the United States that has not been well-studied.